Pharmacokinetics and Pharmacodynamics of Mechanistically Aware Phage Cocktails

ABSTRACT: With only one mechanistically novel antibiotic developed in the past decade with activity versus
resistant Gram-negatives, extensively-drug resistant Pseudomonas aeruginosa (XDR-PA) continues to pose an
urgent threat to human health in the United States and globally. Phages are an encouraging class of complex
biologics, which have substantial bactericidal activity, high target specificity, favorable toxicity profiles, and an
ability to modulate bacterial virulence. Thus far, phage therapy has been limited to individual patient expanded-
access, investigational new drug applications (eIND) as salvage therapy. Unclear consensus on phage therapy
has led to a heterogeneity in dosing and regimen structures, necessitating additional development. Substantial
innovations are required to quantify the unique aspects of phage pharmacokinetic/ pharmacodynamic (PK/PD)
properties. Target-mediated phage disposition (TMPD) is a special case of target-mediated drug disposition,
which addresses the unique aspects of self-dosing at peripheral sites due to phage binding to target bacteria.
This project proposes optimizing the regimen structure to address the TMPD for five clinically relevant
Pseudomonas phage therapeutics (Luz19, E215, PYO2, PAK_P1, and PaCe) with proven activity against
MDR/XDR P. aeruginosa. Published preclinical and pilot eIND data demonstrate that Pseudomonas phages
Luz19, E215, PYO2, PAK_P1, and PaCe exhibit high therapeutic potential in combination (i.e. an “N-phage
cocktail”). The central hypothesis of this proposal is that optimal N-phage cocktail regimens can be generated
using machine learning-led combination of individual phages based on their chief parameters of infectivity, and
the disposition of each phage in the cocktail can be characterized by a novel, platform physiologically based
pharmacokinetic (PBPK) model of target-mediated phage disposition. This project will address the challenges
of phage therapeutics by: developing a translational LC-MS/MS assay for N-phage quantification using in vitro
samples of each phage in antimicrobial growth media then extending the assay for in vivo blood and tissue
matrices (Aim 1). Quantifying the effect of the chief parameters of phage infectivity on bacterial killing and identify
optimal N-phage components and administration patterns using a machine-learning led optimization of PK/PD
(Aim 2). Validating the optimal N-phage cocktail using the HFIM and our leading immunocompromised murine
pneumonia model, while quantifying blood and tissue concentrations of each phage (Aim 3). And tuning and
qualifying a human PBPK model, including descriptions of epithelial lining fluid in the lung and TMPD, based on
whole blood and tissue concentrations of each phage from in vivo murine data (Aim 4). The culmination of these
aims and the main product of this proposal will be the generation of a highly optimized N-phage cocktail and
administration schedule, for use against clinical XDR P. aeruginosa. As a secondary product, we will describe
the phenomenon of TMPD by generating a platform PBPK model for phages that describes whole body
distribution and self-dosing at the infection site, improving the translation of phage-based treatments to humans.

Public health relevance
PROJECT NARRATIVE: Cocktails of individually efficacious phages have been proposed as a strategy to create clinically viable phage therapeutics with sufficient spectrum of activity to combat highly resistant Pseudomonas aeruginosa. As such, this project will generate a highly optimized N-phage cocktail using a hybrid machine learning-pharmacokinetic/pharmacodynamic paradigm to strategically select N-phage components, dose, and administration schedule to maximize the killing of multi- and extensively-drug resistant Pseudomonas aeruginosa. This project will leverage phage whole-body distribution from our murine pneumonia model to establish a human, physiologically based pharmacokinetic model, which will allow detailed assessment of expected human exposures to phage and describe key aspects of target-mediated phage distribution.